Clinical Translational Core

(CORE B- CTC: CLINICAL TRANSLATIONAL CORE)
PROJECT SUMMARY
Description: The Clinical Translational Core (CTC) provides a comprehensive set of services designed to
enhance the impact and rigor of clinical translational research on Intellectual and Developmental Disabilities
(IDD). Select services are novel and unavailable outside of the CTC; other services increase research efficiency
and enhance quality control over study activities common to all CT research. Freeing individual IDDRC users of
the burden of common activities in turn allows users to better deploy resources for innovation and maximizing
the impact of their translational science. CTC services fall into four areas: (1) Assistance with assembling suitably
large study cohorts to support rigorous, well-powered research. Recruitment of large samples is necessary for
studies of developmental disabilities which have diverse clinical manifestations that must be measured and
controlled for in data analyses to garner reproducible results. (2) Creation of study specific interactive databases
and visualization tools which allow labs to track their study progress, efficiently allocate resources and effort, and
prepare study reports and data submissions (e.g., NIMH Data Archive). The CTC, in collaboration with the
Genomics and Data Integration and Neuroimaging and Neurocircuitry cores, support integration of different data
types. (3) Support all phases of IRB and IND protocol preparation, submission and response to stipulations; and
provide concierge services for other freely available research supports already on campus, such as services
offered by CHOP’s Clinical Trials office, and services provided by the Penn/CHOP Clinical and Translational
Science Award (CTSA). (4) Expert clinical assessment support, including support with conventional
psychological measurement; computable phenotypes from bioinformatic analyses of the electronic health
records (EHR); and novel digital phenotyping using computer vision and computational linguistics to achieve
granular measurement of speech, language and observable behaviors (e.g., nonverbal facial expressions and
synchrony between individuals during interactions). These technologies and analytic capabilities are especially
valued as they are not otherwise available on campus or commercially. The CTC will partner with the Preclinical
Models Core on computer vision measurement of animal and human behaviors (e.g., gait), to derive features for
mapping across species in order to more rapidly translate study findings and validate promising treatments.
Relevance to IDDRC Mission: The CTC facilitates interdisciplinary translational research and training in IDDs
(e.g., by working closely with the Leadership Education in Neurodevelopmental and Related Disabilities (LEND)
program). The CTC provides centralized resources as well as novel cutting-edge techniques to support and
advance IDD research linking genes, brain and behavior. The CTC is integral to advancing science that will
impact the lives of those with an intellectual and/or developmental disability.
Eligibility: Services are available to approved users of the CHOP/Penn IDDRC and for cross-site collaborations
with others within the IDDRC network.